EMERGING INFECTIOUS DISEASES RESEARCH PREVAIL I, III, V AND PREVAC MALI

PREVAIL I, PREVAIL III, and PREVAIL V remain incomplete, with inadequate funding remaining on current non-severable task orders to complete necessary laboratory work, data analyses, close-out activities, and publication of findings. DCR has requested the services of Leidos Biomedical Research, Inc. to oversee the completion of the studies under a new non-severable task order.